THERAPEUTIC EFFICACY OF TOPICAL 1,25 DIHYDROXYVITAMIN D3 IN CHILDREN

It has been shown that the active form of vitamin D3 has antiproliferative effects on human skin. The study is to determine the effects of topical vitamin D3 in children.